EPIDEMIOLOGY OF CUTANEOUS CANCERS--PREDICTING SKIN CANCER RISKS

Prevention of melanoma and non-melanoma requires cost-effective interventions focused on definable high and intermediate risk subjects. The proposed research is a continuation and expansion of ongoing case- control studies designed to apply diverse, complementary methods to evaluate the interrelationship of nutrients, nutrient-mediated, medical/medication history, and other known factors for risk of different types of skin cancer. This research will provide new data to facilitate the design of cost-effective cancer control intervention trials and suggest guidelines related to risk of skin cancers. The study population will be composed of white, non-Hispanic residents of southeastern Arizona and provide broad exposure ranges. Nutrients of interest include dietary intake of retinoids, carotenoids, tocopherols, selenium, lipids, and total calories. Nutrient-mediated factors of interest include plasma retinyl palmitate, beta-carotene, lycopene, alphatocopherol, and selenium, plus body size, body composition, body fat, tissue fatty acids. Exposure estimates will be based on interviews, biochemical, anthropometric, and bioelectrical impedance assessment of randomly selected newly-diagnosed pathologically confirmed cases and randomly selected controls. Skin cancer histologic type will be evaluated for differential risk factors.